Cellular determinants of responsiveness to mTOR inhibitors in LAM

Project Summary Abstract
Lymphangioleiomyomatosis (LAM) is a destructive lung disease associated with cystic lung remodeling and
progressive respiratory failure. LAM is caused by TSC1 or TSC2 germline mutations that activate the mechanistic
target of rapamycin complex 1 (mTORC1). Sirolimus, an mTORC1 inhibitor, is the only FDA-approved drug for
LAM, stabilizes lung function and improves symptoms in LAM patients, but disease progression resumes when
sirolimus is discontinued and some patients do not respond to therapy. Despite the important clinical
observations of distinct therapeutic responses to sirolimus in LAM, the cellular mechanisms underlying sirolimus
insensitivity are not understood. The objective of this proposal is to elucidate the mechanisms underlying
sirolimus insensitivity to improve LAM treatment. This proposal is supported by novel preliminary data derived
from both bioinformatics and laboratory findings. Our single cell RNA-sequencing analysis identified a sub-
population of cells that are insensitive to sirolimus in heterogenous cells from Tsc2-null xenografts on sirolimus.
The sub-population of cells was characterized by the increased expression of YAP-WNT pathway genes and
stemness cell markers. The findings were validated using ELT3-245, a Tsc2-null sirolimus-resistant cell line. In
addition, we discovered that YAP-WNT activated downstream target gene expression independently of mTORC1
in LAM lung explants and LAM cells in vitro. Our central hypothesis is that the activation of YAP-WNT crosstalk
in LAM lung cells promotes the “LAM cell stemness state” that drives sirolimus insensitivity. We postulate the
combination of sirolimus and YAP/WNT antagonists will overcome the primary cytostatic effects and enhance
sensitivity to sirolimus. Three specific aims are proposed: Aim 1. Identify the molecular mechanisms
underlying sirolimus insensitivity in LAM. Aim 2. Evaluate the role of YAP-WNT pathways on genes and
processes underlying sirolimus insensitivity in vitro. Aim 3. Determine the effect of YAP-WNT inhibition
on restoration of sirolimus sensitivity in LAM cell survival and lung remodeling in vivo. The completion
of this proposal will provide for the first time: 1) a full spectrum of genomic/epigenomic resources of differential
sirolimus responses in LAM. 2) molecular determinants of acquired sirolimus insensitivity and unique LAM cell
subtype insensitive to sirolimus, 3) molecular insights into the role of YAP-WNT crosstalk in sirolimus
insensitivity, and 4) preclinical proof-of-principle evidence for a novel regimen of YAP-WNT suppression in
restoration of sirolimus sensitivity and inducing remission. Innovative concepts of direct clinical relevance on
YAP-WNT crosstalk leading to LAM cell stemness state and sirolimus insensitivity will be assessed at single cell
resolution coupled with preclinical models using non-invasive optical imaging to longitudinally monitor treatment
responses in mouse lungs. Our work is highly significant and has positive impact as a comprehensive
understanding of the molecular mechanisms underlying sirolimus insensitivity will reveal novel targets and inform
remission-inducing therapeutic strategies for LAM patients and other mTORC1-hyperactive diseases.

Public health relevance
Project Narrative The only FDA-approved drug for treating lymphangioleiomyomatosis (LAM) is sirolimus, which stabilizes lung function and improves symptoms in LAM patients. Disease progression resumes when sirolimus is discontinued, suggesting a cytostatic rather than a cytocidal effect, and not all LAM patients respond. Thus, the goal of this study is to understand the driving forces of sirolimus insensitivity and provide proof-of-concept that blocking WNT/YAP signaling pathways might be a new therapy for LAM patients and other mTORC1-hyperactive diseases.